Converting staphylococcal pathogenicity islands from malevolence to benevolence

Project summary/Abstract
Staphylococcus aureus, causes a wide variety of life-threatening infections, many of which cannot be treated
effectively, owing to antibiotic resistance. Consequently, there is an urgent need for new ways to treat these
infections, which annually cause some 18,000 deaths in the US. We have developed a novel non-antibiotic
method, for treating staphylococcal infections based on the highly mobile staphylococcal pathogenicity islands
(SaPIs). The SaPIs are ~15 kb genetic elements that are stably inserted in the staph chromosome but can be
induced by “helper” phages to excise and replicate. The replicated SaPI DNA is packaged in infectious phage-
like particles which are released upon phage-induced lysis. The SaPIs carry and disseminate genes encoding
superantigen toxins and other virulence factors. Instead of working on the prevention of SaPI spread, we hit
upon the idea of exploiting SaPI spread by converting these agents of disease into agents of therapy –
antibacterial drones (ABDs). To create the ABDs, we have re-engineered the SaPIs, deleting their natural
cargo (toxin genes), increasing their packaging capacity from 15 to >40 kb, and inserting antibacterial modules.
We have also modified the helper phage so that ABD particles are produced in the absence of functional
phage. The ABD particles are administered to an infected animal (or plant), where they attach to the infecting
bacteria, insert their DNA, express their antibacterial cargo genes and thus abrogate the infection. As proof of
principle, we have begun by incorporating into ABDs either CRISPR/cas9 or CRISPR/dcas9 modules with
spacers targeting a chromosomal gene or the promoter region of a global virulence regulator, respectively.
Preliminary studies have shown that the CRISPR/cas9-containing ABD kills S. aureus in vitro by DNA
cleavage, blocks the development of a subcutaneous S. aureus abscess, and rescues mice given a lethal dose
of S. aureus intraperitoneally. The CRISPR/dcas9 containing ABD blocks the expression of staphylococcal
virulence in vitro and blocks the formation of a subcutaneous abscess in vivo. This proposal outlines our
program to develop the ABD system and validate our underlying hypothesis that SaPIs can be converted to
versatile and fully effective anti-staphylococcal therapeutic agents. There are 3 specific aims. In Aim I we will
construct and test ABDs designed to treat the wide array of infections caused by S. aureus. In Aim II, we will
focus on expanding the host range of the ABDs to target diverse S. aureus strains. In Aim III, we will
encapsidate the ABD particles for increased efficacy, test for ABD resistance and immunogenicity, and refine
our procedures for producing and preserving high titer ABD preparations.

Public health relevance
Project(Narrative( ! Staphylococcus aureus, the notorious MRSA, causes life-threatening infections that are often untreatable because of resistance to antibiotics. Yet the development of new antibiotics is at a historic low because it is no longer economical for large drug companies. It is proposed to develop a novel means of treating staphylococcal infections that does not involve antibiotics; rather it involves the transformation of the highly mobile genetic island that encodes toxic shock syndrome toxin into an infectious particle that will kill or disarm an infecting MRSA.